Assessment of Speech Sound Disorders in Latino Preschoolers: An Evidence Based Procedure

Abstract
Bilingual children are often misdiagnosed as having a speech disorder when they truly exhibit
normal development. In addition, speech-language pathologists (SLP) are avoiding the
assessment of bilingual children due to the lack of knowledge and resources necessary for best
practice with this population. Misdiagnosis of speech sound disorders in this population has
long-term emotional, financial, and educational costs. Misdiagnosis of speech disorders in
bilingual children can be prevented if we acquire more information on what constitutes normal
and disordered speech development in the bilingual population. The current research is
designed to validate a model of speech sound production in bilinguals to frame a screening tool
for Latino preschoolers. Due to differences in speech production found in bilingual preschoolers
(Fabiano-Smith & Goldstein, 2010a; 2010b; Fabiano-Smith & Barlow, 2010), an assessment
procedure that evaluates the speech of bilingual preschoolers that takes into account both
English and Spanish is necessary to prevent misdiagnosis of speech sound disorders. The
Specific Aims of the proposed research are to (1) to validate our model of speech sound
production in bilinguals, the PRIMIR 2 model and (2) to improve the existing version of the
assessment procedure utilized in Phase 1 of our research using Item Response and Classical
Test Theory approaches to reliability. Bilingual children with typical and disordered development
will be compared to their English-speaking peers on measures of speech sound ability. Children
will produce sounds in single words and their productions will be phonetically transcribed. Child
productions will be examined, in both English and Spanish and across both languages, on
common diagnostic measures used for monolingual children. Mixed effects regression models
will be used to identify between-language interaction in bilingual speech and the Receiver
Operating Characteristic Curve (ROC) will be used to determine sensitivity and specificity of the
diagnostic measures examined. Item Response Theory (IRT) will be used to identify a set of test
items that are sensitive and specific to bilingual children with suspected speech sound
disorders. Findings will lead to a characterization of typical and disordered speech sound
development in bilingual children and diagnostic guidelines for speech-language pathologists to
use in the differential diagnosis of speech difference from speech disorder. These findings will
reduce diagnostic error in the identification of speech sound disorders in this population,
reducing health disparities for Latino children.

Public health relevance
Latinos are the most populous minority group in the United States and children are the largest segment of the Latino population, comprising the majority of all children in some states (U.S. Census Bureau, 2010b, 2010c). This research will address a large and growing need: Reducing health disparities between Latinos and other racial and ethnic groups. The outcomes of this study will serve to impact (1) the lives of Latino children and their families by limiting the number of children misdiagnosed with speech sound disorders in the United States and (2) speech-language pathologists who are struggling to assess and diagnose the growing number of bilingual children on their caseloads.